Stemming the Tide of Prescription Opioid-Related Morbidity among Injured Workers

Project Summary/Abstract Injured workers with chronic pain have been exposed to dramatic increases in high-dose opioid prescriptions, which have in turn been associated with increasing mortality, work disability, and catastrophic workers' compensation (WC) costs. In 2007, Washington was the first state to implement an opioid guideline with a high-dose threshold, and several other states have since followed suit. State-level opioid prescribing guidelines offer promise in achieving prevention goals, but there has been little systematic evaluation. There are significant knowledge gaps with respect to (1) the prevalence of opioid-related morbidity specifically among injured workers, and (2) opioid policy effectiveness in WC settings. The objective of this study is to quantify the burden of opioid-related morbidity among injured workers, and to demonstrate whether high-dose prescribing guidelines provide a path toward improved worker health outcomes. The central hypothesis is that guidelines that include a component focused on high-dose prescribing practices have had a significant beneficial impact on trends in hospitalizations for opioid poisonings and adverse effects among injured workers. Population- based hospital discharge data for 8 states will be used to assess two specific aims. Aim 1: Quantify the burden of inpatient hospitalizations due to opioid poisoning and opioid adverse effects among workers, and describe demographics. Aim 2: Determine whether trends in the rates of opioid-related morbidity among workers changed after implementation of opioid prescribing guidelines with a high-dose component. To address these aims, rates and trends will be estimated from 2003 through 2014 for 8 states. Staggered implementation of opioid guidelines across multiple states sets the stage for a natural experiment. A multiple baseline interrupted time series design with multiple concurrent comparator states will be used to assess the effect of opioid guidelines on trends in opioid morbidity. These aims are expected to produce several useful outcomes. Aim 1 will document the prevalence of opioid-related morbidity among injured workers that can be used to motivate and support investment in policy changes and prevention opportunities. Aim 2 will provide evidence regarding the effectiveness of a specific policy approach. This study will contribute to R2P by providing state health departments and WC agencies with evidence to support policy changes to protect worker health. This study is innovative because it will be the first study to evaluate the effects of opioid prescribing guidelines on outcomes for injured workers using hospital discharge data for multiple states. It is significant because it will fill important knowledge gaps regarding opioid-related morbidity among injured workers and will support implementation of effective policies targeted at stemming the rising tide of prescription opioid-related morbidity that constitutes an unacceptable and preventable iatrogenic burden on injured workers, WC systems, and society at large.

Public health relevance
Project Narrative The proposed research is relevant to public health and to all NORA sector programs because opioid-related morbidity and mortality constitute a national public health crisis (not industry-specific), and there is an urgent need for increased knowledge concerning ways to prevent serious adverse consequences of prescription opioids among injured workers. By quantifying rates and trends of opioid-related morbidity among injured workers, this project will contribute directly to the Surveillance program, as well as to the surveillance priorities of the Musculoskeletal program due to the higher rates of opioid-related morbidity observed specifically among those with musculoskeletal injuries. This project is particularly relevant to the Total Worker Health program, in that injured workers with chronic pain may have to contend with risks and iatrogenic effects of prescribed opioids after returning to work, and it also contributes to priorities of the Economics program and the Center on WC Studies by more fully characterizing the burden of work injury and illness, and by evaluating state policy interventions to mitigate this burden.